Implementing Integrative HIV-Serious Mental Illness Case Management to Reduce HIV-related Health Disparities

The proposed study will assess implementation of an evidence-based Integrative HIV-SMI Case Management
(IHSCM) approach to care integration for people with HIV and serious mental illness (SMI) in a Ryan White Part
A (RWPA) setting in New York City (NYC). Lacking an integrated system of care for chronic, co-morbid, intensive-
need conditions, people with SMI and HIV—whose rates of HIV infection are 4-10 times higher than the general
population’s—are among the highest service utilizers across multiple care systems yet have among the worst
HIV health outcomes. Guided by our Implementation Research Logic Model based on the Consolidated
Framework for Implementation Research (CFIR) and Expert Recommendations for Implementing Change, our
specific aims are to: 1) Utilize CFIR to identify current practices, gaps, disparities, barriers, and facilitators to
implement IHSCM for integration of care for HIV and SMI in one RWPA setting; 2) Tailor implementation
strategies to conditions identified in Aim 1; 3) Implement strategies tailored in Aim 2, and collect and analyze
interview and survey data to assess outcomes aligned to the Outcomes Crosswalk: acceptability,
appropriateness, feasibility, equity, and patient-centeredness; and 4) Use findings from Aims 1-3 to determine
applicability of IHSCM strategies across other jurisdictions to inform future large-scale implementation. Our goal
is to develop locally defined strategies for integrating care for people with two chronic, comorbid, intensive-need
conditions to achieve improved health outcomes and secondary prevention. Building on our prior HIV-behavioral
health care integration planning supplement, which successfully coalesced diverse system settings and
jurisdictions to inform directions for new implementation research, and using a mixed methods design, we will
evaluate the implementation of IHSCM in a RWPA setting in NYC, with potential to be scaled up by the New
York City Department of Health and Mental Hygiene and RWPA settings across NYC to improve HIV outcomes
and reduce health disparities in a NYC EHE priority population. This study addresses two pillars of the federal
EHE Plan, Treat and Prevent, as well as key NIH HIV/AIDS high-priority research areas: 1) Address HIV co-
morbidities through research designed to manage these conditions; and 2) Advance Cross-Cutting Areas of
research in the behavioral and social sciences, epidemiology, implementation science, and information
dissemination. This project is responsive to the Supplement Announcement in several ways: (1) it is an equity-
focused approach that will reduce disparities in HIV treatment and related health outcomes; (2) it addresses a
highly stigmatized priority population (people with SMI) as stipulated in the NYC EHE Plan and its Ryan White
Planning Council; (3) it builds upon meaningful partnerships across critical government public health, community,
research, and implementation organizations in NYC and upon a strong collaboration with on-the-ground service
delivery providers and PWH; and (4) it will provide evidence tailored to the local context of the HIV epidemic
through testing of an evidence-based intervention using the HIV Implementation Outcomes Crosswalk.

Public health relevance
Advances in HIV treatment and prevention, improved healthcare data systems, and a shift to a population health focus on treating the whole person has led to greater awareness of untreated mental health conditions as major barriers to optimal HIV health outcomes. The lack of care integration and the impact of social determinants of health is especially burdensome for people with serious mental illness whose care is generally conducted in separate systems with little coordination. Implementing a case management approach specifically for people with these two chronic conditions can potentially bridge care systems to improve the health of those in greatest need who are receiving inconsistent care, engaging and disengaging without effective monitoring, and struggling to sustain medication adherence and viral suppression.